Leveraging protein-engineered biomaterials and bioorthogonal chemistries to elucidate the role of non-elastic matrix properties in regulating cell fate

PROJECT SUMMARY
Cells are exquisitely sensitive to the mechanical properties of their environment, altering fundamental processes
like adhesion, migration, cell division, and cell fate specification in response to how the polymers comprising the
extracellular matrix (ECM) and surrounding cells react to applied forces. Thus, environmental mechanical cues
serve as crucial drivers of development, homeostasis, tissue regeneration, and disease progression. To
understand the molecular mechanisms underpinning cellular mechanosensing, engineered systems are required
that can decouple the influence of multiple confounding parameters, such as matrix stiffness (elasticity), viscous
force dissipation, plastic deformation, microstructure, and adhesive cues. While there is an extensive body of
literature exploring how cells sense and respond to stiffness and, increasingly, viscous force dissipation, present
materials systems used in these studies are only capable of independently controlling one or two mechanical
parameters at a time and make use of chemistries that can react with biologically relevant molecules, leading to
altered material properties over time and potential off-target effects on cells. My lab leverages interdisciplinary
expertise in bioorthogonal chemistries, protein engineered biomaterials, and stem cell biology to develop new
platforms to study fundamental mechanisms of cellular mechanosensing under physiologically relevant
conditions. This includes developing new chemistries and hydrogel materials to enable simultaneous,
independent, and dynamic tuning of matrix stiffness, viscous force dissipation, and presentation of cell adhesive
cues within 3D organotypic ensembles of cells. Recent efforts have focused on the development of highly-
selective, stimuli-responsive chemistries to alter the stiffness and force dissipation rate of hydrogel materials on
demand to model changes that occur in various diseases and during aging. We have also developed new protein
engineered materials with genetically encoded viscoelasticity and are applying these materials to develop
chemically-defined and highly tunable 3D organotypic culture platforms. In this proposal, we extend our work by
developing new bioorthogonal chemistries that will enable tuning of viscoelastic force dissipation without off-
target chemical reactivity, permitting casual relationships to be identified in complex systems over long culture
durations without deterioration of material properties. We will also introduce new mechanically-labile crosslinking
chemistries to provide additional modes of plastic deformation induced by cells. Finally, we will address a
limitation of cellular force generation measurement techniques in native-like viscoelastic materials by developing
new force sensors through protein engineering and chemoenzymatic modifications. The platforms developed in
this proposal will be broadly useful to elucidate the molecular mechanisms by which cells sense and respond to
changes in their mechanical microenvironment and to study how these changes drive desired phenotypes during
development and tissue regeneration and undesired phenotypes during aging and disease progression.

Public health relevance
PROJECT NARRATIVE Cells are surrounded by a complex and dynamic polymeric meshwork that connects cells into functional tissues and organs. These polymeric materials provide mechanical and structural cues that direct cellular processes involved in development and tissue maintenance and often become dysregulated in disease, but our understanding of how these physical cues regulate cellular behavior is limited by the lack of suitable engineered systems to study the isolated effects of these important parameters. This project will develop new biomaterials platforms that recapitulate the dynamic and complex mechanical properties of native tissues and then apply these well-controlled platforms to establish causal relationships between physical cues and a broad range of cellular behaviors.